Role of miRNA from amelogenin exon4 in enamel formation

Project Summary/Abstract
Genetics of enamel formation is not well studied yet. In humans, hereditary enamel defects (HED) occurs as a
non-syndromic enamel conditions (amelogenesis imperfecta/AI) or syndromic conditions affecting tissues or
organs in addition to the enamel phenotype. At least 73 genes are known to involve in HED. Amelogenin gene
is the most essential one of those genes, and causes X-linked AI when mutated. Amelogenin gene is processed
via alternative splicing to produce the two major mRNAs for proteins with distinct functions. During these events,
exon4 is always spliced out, and the importance of the spliced-out exon4 has not been well studied. We recently
published that a novel microRNA (miRNA) is derived from the spliced-out exon4 (miR-exon4). This miR-exon4
regulates expression of Runx2 in ameloblasts. In tooth, Runx2 is known associate with HED, thus the critical
role of miR-exon4 for enamel formation is suggested. miRNAs play important roles in tooth formation.
Nevertheless, clear links between the miRNAs, tooth development and diseases have yet to be established.
Particularly, how miR-exon4 is involved in normal and pathologic enamel formation is not clear. Enamel is an
indispensable tissue layer of the tooth, since defective enamel severely affects the quality of life for HED patients
by causing poor aesthetics, hypersensitive tooth, reduced mechanical property and occlusion. Hence, there is
an urgent necessity to increase our knowledge of this newly discovered miR-exon4 associated with enamel
formation. Our long-term goal is to thoroughly understand how molecular signaling directs enamel formation,
particularly the involvement of molecules derived from amelogenin gene. Our overall objective for this proposal
is to discover how miR-exon4 formation is initiated and how it contributes to enamel formation. In our published
and preliminary studies, we found that miR-exon4 regulates HED-causative genes including Runx2. Our in silico
analysis demonstrated that most of the amelogenin mutations causing X-linked AI disrupt alternative splicing,
which will affect production of miR-exon4. Taken together, our central hypothesis is that production of miR-exon4
is initiated via alternative splicing, and miR-exon4 regulates molecules involved in HED. This hypothesis will be
tested with the following specific aims; 1) Determine how alternative splicing of exon4 is regulated to initiate miR-
exon4 formation, 2) Reveal the mechanism by which miR-exon4 regulates Runx2 expression during enamel
formation, and 3) Understand how miR-exon4 plays important roles in enamel formation in vivo. These
knowledge will advance our understanding of molecular mechanisms regulating enamel formation, in particular,
the mechanisms associated with the etiology of X-linked AI. Our findings will provide useful knowledge
foundation to develop the strategies in the precision medicine to customize the treatment for X-linked AI.
Moreover, as the role of miR-exon4 will be further clarified and established, miR-exon4 will potentially be used
as a therapeutic molecule to improve the quality of the enamel in the future.

Public health relevance
PROJECT NARRATIVE: How much genetics associate with enamel formation are known? This study focuses on molecular regulatory mechanisms of enamel formation and enamel defects via a novel miRNA derived from amelogenin gene. The outcomes of this study will greatly improve our genetic knowledge of enamel formation in preparation for molecular based precision medicine, either for developing the customized treatment for X-linked AI, or applying the novel miRNA as a therapeutic molecule to improve the quality of the enamel, including the hereditary enamel defects.